How bacterial SMC complexes organize chromosomes

Project Summary
The primary goal of our funded research (1R01GM141242) is to understand how the chromosome is organized
and segregated during the cell cycle. We focus on the molecular mechanisms of SMC condensin complex, which
is a key player for chromosome dynamics from bacteria to humans. Our projects combine genetic, molecular,
cytological, and biochemical approaches. Our research requires a lot of samples to be stored at -80˚C. However,
our existing -80˚C is full of essential reagents and we are in need of a new freezer. In this application for
Administrative Supplements for Equipment, I am requesting a Cryocube F740HI Freezer, which will allow us to
continue to perform the experiments proposed in the parent grant.

Public health relevance
Project Narrative Faithful segregation of chromosomes underlies genome integrity in all organisms. My R01GM141242 project aims to identify the mechanisms by which broadly conserved structural maintenance of chromosomes (SMC) complexes organize and compact replicated chromosomes in the cell. In this supplement proposal, I am requesting funds to purchase a Cryocube F740HI -80˚C freezer to accommodate our growing need for reagents storage at ultralow temperature.